Deciphering the cell type specific control of HCMV tegument-delivered pp71 subcellular localization

Herpesviruses package virally-encoded transcriptional activating proteins into the tegument layer of their virions. The tegument transactivator encoded by human cytomegalovirus (HCMV) is the pp71 protein. When cells are productively infected, pp71 is released into the cytoplasm, translocates to the nucleus, and activates viral immediate early (IE) transcription. Herpesviruses also establish latent infections where productive phase gene expression is absent or attenuated. Tegument-delivered pp71 remains in the cytoplasm of the primary CD34+ cells where HCMV establishes latency. Thus, the subcellular localization of tegument-delivered pp71 differentially correlates with IE transcriptional activity during lytic infection (pp71 in the nucleus, IE transcription on) and latency (pp71 in the cytoplasm, IE transcription off). Here, we propose to identify the natural way in which the subcellular localization of tegument-delivered pp71 is controlled as a first step toward developing a method to artificially control it, and thus control the fate of an HCMV infection (lytic or latent).

Public health relevance
Narrative Human cytomegalovirus infects almost everyone. It causes birth defects and disease in people sick with cancer, AIDS, and those undergoing organ transplants. It also seems to exacerbate cardiovascular diseases, to adversely affect the ability of the elderly to fight off other infectious diseases, and may be indirectly related to human glioblastoma multiforme brain tumors. HCMV can hide in the body in a latent state and reactivate at any time to cause disease and to spread from person to person. This work will study how HCMV establishes this latent state, with the hopes of identifying ways to fight the virus with antiviral drugs.